Meningococcal Immunization Against Gonococcal Infection Clinical Trial

To support a phase II randomized, placebo-controlled study, to assess efficacy of meningococcal Group B vaccine (Bexsero©, GSK) in preventing gonorrhea.